SWOG Network Group Operations Center of the NCTN

The impact statement in SWOG's network operations grant application succinctly summarizes our work
and our goals: By continuously improving inclusion, engagement, and scientific innovation,
SWOG will enhance cancer clinical trial development and conduct, reducing the burden of human
neoplasm.
The SWOG National Clinical Trials Network Group has established itself as an innovative, collaborative,
a n d cost-effective NCTN constituent. SWOG has 60 years of trial experience, and its work has led to the
Food and Drug Administration approval of 14 regimens, changing and informing oncologic practice
hundreds of time more. In our 2013 grant application, we promised to make unique contributions to the
new NCTN enterprise, and we successfully did so over the last five years. We are strongly committed to
furthering our efforts over the next six. SWOG designs and directs high-value, pathway- and immune-
driven oncology research, with the goal of achieving practice-changing results that are meaningful to both
persons affected by cancer and investigators. The group's current network includes more than 1,000
member sites, with 5,000 physicians who practice across the United States, Canada, South Korea, Mexico,
Saudi Arabia, and South America. Twenty-three NCI-designated cancer centers number among our
members, as do 22 Specialized Programs in Oncology Research Excellence. From early 2014 through
mid-2017, SWOG investigators published more than 188 cancer treatment articles and abstracts, and
enrolled 12,819 patients into NCTN therapeutic trials. SWOG actively collaborates in NCTN direct
research and administrative functions and has developed training and education tools used throughout
the network.
SWOG's mission is to significantly improve lives through cancer clinical trials and translational
research. The following guiding principles, ratified in 9/2017, are the foundation upon which we build to
achieve that end:
— We make patients our absolute highest priority
— We ensure that the best science drives our research
— We embrace and encourage diversity in leadership and membership, to effectively solve problems
in cancer
— We demand integrity, accountability, and ethical behavior in SWOG
— We foster and mentor young investigators, to ensure excellent clinical research for future generations
Over the next grant cycle, we will provide an efficient, innovative, and nimble network capable of
developing and conducting abroad framework of clinical and translational trials; we will
meaningfully contribute to the NCTN; and we will help patients lead longer and meaningful lives. SWOG
will remain an innovative force in the design of the next generation of oncologic therapies.

Public health relevance
PROJECT NARRATIVE SWOG’s clinical and translational research will lead to a better understanding of the biology underlying neoplastic disease and will ultimately enable those potentially affected by cancer to lead longer, healthier lives.